CRCNS: Assessing long-term impacts of disruption to large-scale brain networks

Large-scale complex networks support brain function across the lifespan, and features of brain networks
are hypothesized to confer both vulnerability and resilience to the brain changes that accompany healthy
and pathological aging. Brain network organization can be characterized during resting wakefulness using
functional magnetic resonance imaging and system segregation is a measure of this organization which
quantifies the degree to which an individual’s brain network contains functionally distinct brain systems. In
healthy adult humans, increasing age is associated with decreasing system segregation; declining system
segregation is associated with worsening memory ability, alterations in brain activity, and is prognostic of
Alzheimer’s Disease dementia beyond brain atrophy and pathology. The precise mechanism of
aging-accompanied brain network changes is presently unclear and gaining a deeper understanding of
them would be greatly advanced by the development of non-human models of brain network aging. A
precision imaging-based approach will be used to develop and characterize a comprehensive longitudinal
description of functional brain network changes across the mouse lifespan. Awake resting-state fMRI will
be measured in individual mice as they grow older (from 3 to 21 months) and will be used to quantify
changes in brain network organization (particularly segregation). Brain network changes will be related to
behavior and cognition (including measures of memory, learning, and sensory-motor function), both as a
function of age and sex. Targeted lesions to vulnerable brain network locations (network hubs) will be
administered at younger and older ages, to test the causal contributions of hub nodes towards maintaining
brain network integrity, and evaluate the susceptibility of older-age brain networks to focal damage. This
work will broaden understanding of complex network function, large-scale network mechanisms
underlying aging-related behavioral alterations, and the impacts of brain network disruption occurring at
different life stages. The characterization of large-scale brain network organization with respect to
aging-related decline in the intact brain, together with the use of targeted lesions, will set the stage to
study the impact of neurodevelopmental and neurodegenerative pathologies on brain network
organization and function in a valuable cross-species model.

Public health relevance
Age-related cognitive dysfunction is linked to changes in functional brain network organization in humans. The development of a lifespan mouse model of a functional connectome that directly parallels human work will illuminate sources of risk and resilience to age-related decline, and provide a translational bridge to evaluate the mechanisms of cognitive decline in both healthy and diseased aging.